Flexible biomarker evaluation through a cost-effective data collection mechanism

Project Summary/Abstract There exists an undeniable need for biologists and medical researchers to identify new biomarkers (biological markers) which are useful in determining exposure and/or for the purposes of disease detection. Consider- ing the rising cost of assessing new biomarkers, it is reasonable to believe that this area of research has the potential to be stunted due to funding concerns. My proposal aims at offering these researchers an alternate data collection mechanism and ﬂexible statistical tools to more cost-effectively identify meaningful biomarkers. Traditionally, biomarkers are evaluated by collecting specimens from individuals within target populations which are subsequently tested. Alternatively, the proposed data collection mechanism speciﬁes that several individual specimens are mixed to form a pool which is then tested. The salient feature of pooling is twofold: (1) one assay measures several individuals' biomarker levels, which reduces costs; (2) mixing several individual specimens provides a sufﬁcient amount of the biomarker to avoid the limit of detection. The statistical literature surrounding the use of pooling for biomarker assessment predominantly focuses on the estimation of the receiver operating characteristic (ROC) curve and the area under the curve. Regretfully, these works assume restrictive assumptions about the underlying distribution of the individual biomarker levels. If such assumptions are wrong, incorrect inference could be produced. To remedy this limitation, I propose ﬂexible methods that are robust to those assumptions. Speciﬁcally, I will propose a nonparametric estimator of the ROC curve based on pooled measurements, which will then be used to test whether the biomarker is a good discriminator (Speciﬁc Aim 1). Then I will extend the nonparametric method to to estimate a covariate- adjusted ROC curve from pooled measurements (Speciﬁc Aim 2). The third speciﬁc aim will ﬁnd the optimal linear combination of multiple biomarkers in order to improve the discriminatory ability. In addition, I will develop statistical software that easily implements the proposed methods. My proposal is innovative because it offers methods that could shift the current biomarker research paradigm into a more comprehensive and cost-effective regime. The successful completion of my proposal could signiﬁcantly impact biological and medical research practices, by allowing for the assessment of biomarkers that previously could not be appropriately evaluated due to cost considerations and the lack of statistically sound methodology.

Public health relevance
Narrative This proposal will promote the use of pooling as a cost-effective data collection mechanism in biomarker evalua- tion. Robust and ﬂexible statistical methodology for evaluating biomarkers, based on pooled measurements, will be developed along with statistical software that implements the same. This work will impact public health com- munity by allowing researchers to more efﬁciently and thoroughly investigate new biomarkers for the purposes of disease and exposure detection, when the budget and/or the number of specimens is limited.